Role of a RAG1-DCAF1(VprBP)-Ezh2 axis in B cell development

PROJECT SUMMARY
B and T lymphocytes form the foundation of our adaptive immune system, which is based on specific
recognition of foreign molecules by structurally diverse surface antigen receptors. Structural diversity in these
receptors originates from RAG (recombination activating gene)-mediated V(D)J recombination that assembles
antigen receptor genes during lymphocyte development. However, V(D)J recombination is not always benign,
as aberrant rearrangement can contribute to genomic instability and cancer in lymphocytes. We previously
showed that the amino-terminal 215 residues of RAG1, which is dispensable for RAG endonuclease activity,
constrains V(D)J recombination by recruiting Vpr Binding Protein (VprBP) and its associated Cullin4-DDB1-
Rbx1 (CRL4) E3 ubiquitin ligase complex to mediate timely RAG1 degradation. Interestingly, VprBP (also
called DCAF1) was recently found to stabilize the histone-lysine N-methyltransferase Enhancer of zeste
homolog 2 (Ezh2), which catalyzes the addition of methyl groups to histone H3 at lysine 27 (H3K27) by the
Polycomb Repressive Complex 2 (PRC2). Trimethylation of H3K27 (H3K27me3) is generally considered to
promote gene silencing. In mice, B lineage-specific loss of Ezh2 expression arrests B cell development at the
pro-B to pre-B cell transition, and selectively impairs rearrangement of the distal immunoglobulin (Ig) VHJ558
gene family. This phenotype resembles that observed in mice lacking VprBP in B cells. Truncating the first
215 residues of RAG1 in mice to eliminate the VprBP binding site (R1215 mice) confers a less severe
phenotype, but nevertheless impairs short-range Ig D-J rearrangement for reasons that remain unclear. These
observations lead us to hypothesize that VprBP stabilizes Ezh2 in B cells to promote PRC2 formation, H3K27
methylation, transcriptional programs, and immune repertoire in early B lineage cells, and through VprBPs
association with full-length RAG1, specifically regulates H3K27 methylation within the Igh locus to regulate
short-range Ig D-J rearrangement. This hypothesis will be tested by experiments described in two broad Aims.
In Aim I of this project, we will: (a) establish the concordance of the phenotypes presented by mice lacking
VprBP or Ezh2 in the B lineage when rescued by enforced Bcl2 expression; (b) compare Ezh2, total H3, and
H3K27me3 protein levels in wild-type and VprBP-deficient B cells, using Ezh2-deficient B cells as a negative
control; and (c) establish VprBP-dependent Ezh2 association with PRC2 subunits EED and SUZ12 in primary
B cells. In Aim II of this project, we will use RNA, immune repertoire, and H3K27me3 “Cut&Run” sequencing
approaches to analyze and compare the transcriptome, Ig gene usage, and localization of H3K27me3 marks in
sorted pro-B and pre-B cells from wild-type, VprBP-deficient, Ezh2-deficient, and R1215-expressing B cells.
Establishing that the RAG1-VprBP-Ezh2-H3K27me3 axis regulates V(D)J recombination would be
conceptually innovative, as it provides a means for the RAGs to locally modify Ig gene accessibility and
expression within antigen receptor loci by recruiting VprBP and regulating Ezh2 activity.

Public health relevance
PROJECT NARRATIVE V(D)J recombination is a DNA rearrangement process that is responsible for generating a diverse population of B and T cells that together provide highly specific immunity to pathogenic microorganisms. The proposed research will determine if a protein called VprBP(DCAF1) stabilizes the histone-lysine N-methyltransferase Enhancer of zeste homolog 2 (Ezh2) in primary B cells, and through VprBP’s association with the RAG1 protein that initiates V(D)J recombination, modulates Ezh2 methyltransferase activity on histone H3 to regulate gene expression and immune repertoire in B cells. This work will not only illuminate a novel role for VprBP in regulating V(D)J recombination, but will also reveal how VprBP(DCAF1) and Ezh2 collaborate to support transcriptional programs during early B cell development.